The Single Cell Landscape of Early Human Diabetic Nephropathy

Project Summary/Abstract
Diabetic kidney disease is the leading cause of end-stage renal disease and a major contributor to morbidity
and mortality. We have successfully performed single nucleus RNA sequencing (snRNAseq) and single
nucleus ATAC sequencing (snATACseq) on five healthy control and eight diabetic kidney samples to measure
the cell-type-specific transcriptional and chromatin conformational profile of early human diabetic kidney
disease. The differentially expressed transcripts in the diabetic proximal tubule showed upregulation of
gluconeogenic genes and enrichment of pathways involved in corticosteroid signaling. This proposal aims to
integrate snRNAseq and snATACseq to determine whether there are changes in chromatin accessibility in the
enhancer and promoter regions of corticosteroid-sensitive genes that regulate gluconeogenesis. We will
subsequently validate our in vivo findings with an in vitro model of diabetic injury and a diabetic mouse model.
This proposal builds on the principal investigator’s previous research experience and clinical training.
Currently, Dr. Parker Wilson is spending 25% of his time on the renal and molecular pathology clinical services
with the remaining 75% allocated to basic research in Dr. Benjamin Humphreys’ laboratory. Dr. Wilson has an
established mentoring relationship with Dr. Humphreys and has published his analysis of snRNAseq data from
human diabetic kidney as a first author in PNAS. In addition, Dr. Wilson has a recently-accepted co-first author
manuscript describing multimodal snRNAseq and snATACseq integration in the healthy adult kidney in Nature
Communications. These findings provide the foundation for this application, which will focus on expanding Dr.
Wilson’s scientific skills in single cell methods, bioinformatics analysis and models of diabetic kidney injury.
The career development goals will be achieved through mentoring by Dr. Humphreys and an advisory
committee with expertise in regulation of chromatin conformation, bioinformatics and diabetic nephropathy. Dr.
Wilson will undertake didactic coursework in research ethics, scientific communication and grant writing,
molecular biology and advanced computer programming to further his existing knowledgebase. The work will
take place at Washington University, which has a strong history of mentoring successful physician-scientists.
Completion of this career development award will build a solid foundation for Dr. Wilson as he pursues
independence and R01-level funding.

Public health relevance
Project Narrative Diabetic nephropathy is the leading cause of end-stage renal disease and a major contributor to morbidity and mortality. Despite antihypertensive therapy and glycemic control, an estimated 40% of patients ultimately develop chronic kidney disease. Single cell sequencing of early diabetic kidney samples can reveal the cell types and pathways that contribute to disease progression and help to identify novel treatment targets.